Therapeutic Oligonucleotide Platform Biologics Chemistry, Manufacturing and Controls (CMC) Subject Matter Expert Consultant

The specific consultant SME technical areas required are outlined below. 1. Biologics Chemistry, Manufacturing and Controls (CMC) Oligonucleotide Therapeutics SMEs Subject matter experts in manufacturing of oligonucleotide therapeutics platforms, including but not limited to modalities such as antisense oligonucleotide -ASOs, small interfering RNAs -siRNAs, etc are required. Biologics CMC consultants will be expected to provide senior-level chemistry, manufacturing and controls expertise and contribute feedback and guidance on projects to the NIH and to LDT members through conference calls and by email. The role of the CMC SME consultant may include, but is not limited to, the following responsibilities and tasks: a) Review and comment on the adequacy of biologic manufacturing including scale-up, analytical method development, and process development (upstream and downstream processing) approaches proposed by PIs and CMOs b) In partnership with other consultants, contractors, and the NIH staff, advise, strategically plan, and manage CMC to facilitate preclinical evaluation and safety testing, IND submission, and clinical studies c) Provide strategy and feedback on biologics process development and manufacturing plans proposed by the team d) Provide feedback on therapeutic oligonucleotide sequences and synthesis processes proposed by the team e) Serve as the CMC expert in order to identify potential product manufacturing challenges and suggest strategies to address these challenges f) Facilitate Team discussions via telephone and email regarding assigned CMC efforts g) Provide strategic guidance for the continued development and improvement of the URGenT program